The Neuroprotective Effects of Sulforaphane in VPA-Induced Models of Autism

Many environmental pollutants alter physiological homeostasis, and this dysregulation is especially harmful
when it occurs embryonically. Unfortunately, pregnant women are commonly exposed to multiple environmental
contaminants, which increase the risk of a variety of developmental disorders. For example, several pollutants
are known to disrupt neural development. In fact, animal studies show causal links between some pollutants and
development of behavior that is typical of autism spectrum disorders (ASD), a group of devastating
neurodevelopmental disorders that have become all too common in humans. In fact, neurodevelopmental
disorders, such as autism spectrum disorders (ASD), are the fastest growing developmental disabilities in the
United States. In 2016 the prevalence of ASD was nearly 2% and its incidence has doubled in the last 20 years.
Indeed, it is widely recognized that genetic and environmental factors, such as exposure to pollutants, interact
to increase the risk of developing an ASD. While we have evolved defense mechanisms to mitigate the effects
of natural toxins, they are insufficient to combat today’s ever-increasing environmental contamination. However,
if we can augment our endogenous preventative mechanisms, we can prevent pollutant-induced disabilities. We
recently determined in the mouse model that pollutant-exposed fetuses supplemented with sulforaphane, a
derivative of broccoli, have less frequent and less severe birth defects relative to embryos exposed to only
pollutants. This project will test the generality of that rescue effect by determining the mechanisms through which
we can prevent chemical-induced alterations in neural circuitry and associated behaviors. Fetal exposure to
valproic acid (VPA) is known to cause ASD in humans and autism-like behavior in mice. Here we will exploit this
model to understand the mechanisms of resilience that sulforaphane upregulates to protect the fetus from
developing autism. Specifically, using human brain organoids we will establish the mechanisms by which it
reduces VPA-mediated alterations in neural circuit development. We will then assess the impact of sulforaphane
on VPA-induced behavioral outcomes in the VPA mouse model. This research benefits from the combined
strengths of a robust model of chemical-induced ASD, a human brain microphysiological system, and a mouse
behavioral model. This unprecedented approach will allow us to identify preventative measures that facilitate
normal neural circuit development in a toxic environment.

Public health relevance
Environmental contaminants, which are ubiquitous and ever-increasing, strongly contribute to neurodevelopmental disorders, yet little research focuses on preventative mechanisms to counteract the devastating effects of environmental contamination. The following research uses both human brain spheroids and a mouse behavioral model to address whether the phytochemical, sulforaphane, can prevent contamination- induced neural circuit disruption and the development of autism-associated behaviors. This research represents a necessary first step for the development of pre-natal supplements to counteract the devastating effects of environmental contamination.